Resource Core

Modified Project Summary/Abstract Section

ABSTRACT: RESOURCE CORE The TRANSFORM Resource Core supports the Center Research Projects (Project 1: Family Health Study; Project 2: Close Relationships Study), the Pilot Study (Resilient Roots), the Dissemination and Outreach Core (DOC), TRANSFORM early-career scholars, and leadership within TRANSFORM. The Resource Core offers integration, cohesion, and cost effectiveness to TRANSFORM through a number of support services. This approach facilitates productivity and efficiency while minimizing duplication of efforts across Projects and Cores within the Center. The Resource Core offers expertise that converges to provide synergized support to TRANSFORM as an integrated Center, that could not be established if the Research Projects were conducted as individual R01s and R21s. It also promotes sustainability of the Center by supporting current and future research endeavors. The Resource Core is central to the TRANSFORM mission to foster the next generation of transdisciplinary child abuse and neglect (CAN) researchers and to disseminate high quality CAN research. The specific aims are as follows: Aim 1: Provide statistical support to the TRANSFORM Research Projects, Pilot Study, and DOC. Aim 2: Promote the next generation of child abuse and neglect (CAN) scholars by providing mentoring and training in data analysis, interpretation, and dissemination of the TRANSFORM Data Archive. The Data Archive is a national treasure of archived data collected by pioneers in the field of CAN sequalae and preventive intervention, as well as closely associated topics. Aim 3: Provide research design and data analytic support to early-career and senior TRANSFORM scholars during the development of future research initiatives and grant proposal planning. Aim 4: Support the Center on integrated data analysis and measurement synchronization across projects and initiatives. Aim 5: Augment research projects (archived and currently proposed projects) with multisector legal, police, and health service utilization record data. Aim 6: Facilitate recruitment and retention of participants across projects. Aim 7: Provide an infrastructure for data organization and management, data quality review, and data sharing within TRANSFORM.